microRNA-based and novel molecular therapeutics in thoracic cancers

This project continues to be developed. We are performing bioinformatic analyses to survey genomic databases of mesothelioma to infer microRNA and transcription factors regulatory pairings (in a feedback loop circuit or other relevant motif) of high significance. We are systematically testing the functional relevance of such circuits in vitro and validating phenotypic consequences in vivo. Several candidate microRNA associated with and biologically active in mesothelioma have been reported from our lab with several more in the pipeline. To translate this body of work we have developed a clinical delivery platform based on peptide nanoparticle-hydrogel composite material that can effectively deliver microRNA to tumor cells (in vivo mesothelioma models). Refinements are being made to optimize efficacy and performance characteristics (e.g. scale-up manufacturing) of this hydrogel-based system. New groundwork is established to create the next generation mesothelial cell model for mesothelioma oncogenesis investigation using 3D bioprinting techniques. In this new model construct we are using multiple cell types derived from human tissues to reconstruct the equivalent of ex-vivo pleural membrane "organs".